Mentoring patient-oriented research in deep phenotyping of cardiac function for heart failure prevention

Dr Amil Shah is an Associate Professor of Medicine at Harvard Medical School and an active clinical
cardiologist and cardiovascular imager at Brigham and Women's Hospital (BWH). His overall career goal is to
make substantial contributions to the diagnosis, treatment, and prevention of heart failure (HF) – and HF with
preserved ejection fraction (HFpEF) in particular – through impactful research and effective mentoring of the
next generation of investigators. He has developed a successful, independent patient oriented research (POR)
program aiming to define the cardiac perturbations responsible for HFpEF by integrating cardiac imaging into
prospective hospital-based physiologic studies, multicenter epidemiologic cohorts, and randomized clinical
trials. He has led impactful publications informing HFpEF pathophysiology, diagnosis, and management, and
has secured continuous NIH funding (PI on 2 active R01 grants). He has been primary mentor to 22 trainees
to-date, and his program provides a unique platform for training in POR which is amplified by integration with
the Harvard CTSA, BWH cardiovascular imaging T32 program, and degree-granting programs in clinical
investigation at Harvard Medical School and School of Public Health. His objectives for this K24 proposal are
(1) to improve the quality and scope of his mentoring by engaging in didactic and peer-led workshops; (2) to
expand his research program to include `-omic' science; and (3) to develop expertise in analysis of high-
dimensional `-omic' data to relate to imaging phenotypes and clinical outcomes. Protected time from the K24
will enable Dr Shah to pursue didactic and peer-led training in mentoring, to expand his mentoring activities,
and to engage in coursework and `hands-on' training in `-omic' science. Funds from the K24 will support
expansion of his research program into translational proteomics and genomics, including computational
biology support. HFpEF is common, morbid, and increasing in prevalence, but no efficacious disease-specific
therapy currently exists. While LV dysfunction underlying HFpEF is an intense focus of investigation, little is
known regarding biological pathways promoting the preservation of cardiac function in the face of detrimental
co-morbidities (cardiac resilience). This is a critical missed opportunity to develop interventions promoting
normal cardiac function to prevent HF. The specific scientific aims of this proposal are to define circulating
individual proteins and protein networks that (1) positively and negatively correlate with exercise-
hemodynamic perturbations characteristic of HFpEF; (2) associate with cardiac resilience in late life; and (3)
are most likely to be mediators of cardiac resilience based on studies using genomic data. Aim 1 will occur in
patients prospectively enrolled at BWH to undergo invasive exercise testing. Aims 2 and 3 will be performed in
the Atherosclerosis Risk in Communities cohort, with replication in the Jackson Heart Study. Synthesizing
these `-omic' approaches with his existing research program will uniquely position Dr Shah to vertically
advance understanding of HFpEF pathobiology, while enriching training opportunities in POR for his mentees.

Public health relevance
Project Narrative Heart failure with preserved ejection fraction (HFpEF) disproportionately burdens elders and African Americans causing substantial morbidity and mortality, and has no effective treatment making it an especially pressing public health concern. This project will take the novel approach of investigating biologic pathways that mediate cardiac resilience in these high-risk populations by relating proteomics (4,931 circulating proteins) to exercise hemodynamics, longitudinal changes in cardiac function, and detailed genomics. In identifying new targets for interventions promoting cardiac health to prevent HFpEF, this project will also support the expansion of Dr Shah's patient oriented research program and enhance the quality and breadth of training for his mentees.